AI-based Cardiac CT

Abstract
Cardiovascular diseases (CVDs) are the leading cause of morbidity and mortality, with 19 million deaths globally
in 2020 alone. Central to management of CVDs is deepening our knowledge of physiology and pathology of the
heart. Major barriers to our greater understanding of the heart include its deep location and fast dynamics.
Evidence from invasive coronary angiography indicates that the maximum velocity of cardiac structures is 52.5
mm/s, requiring a scan time of 19.1ms to eliminate motion artifacts. To achieve this temporal resolution with
CT is extremely challenging. There have been substantial gains in CT hardware and software over the last
decades (whole heart, dual-source, dedicated cardiac CT, and various approaches to cardiac motion
compensation with ECG-gating) that have transformed coronary CT angiography into a robust and viable clinical
tool. However, owing to the 140ms temporal resolution of current whole heart CT scanners, diagnosis is still
challenging in patients who have irregular and/or fast heart rates especially in cases of arrhythmias and
tachycardia, which commonly occur in older adults, many of whom exhibit atrial fibrillation.
Here we will apply deep learning to radically improve cardiac CT reconstruction by attaining significantly higher
spatial resolution, lower radiation exposure, and better image quality on both modern and legacy CT hardware.
To improve wide-area-detector cardiac CT performance, we will develop a limited-angle reconstruction algorithm
in the Analytic, Compressive, Iterative, and Deep (ACID) reconstruction framework that integrates a deep
network trained on large data, sparsity-promotion, analytic modeling, and iterative refinement. For the first time,
two of the preeminent advances in signal processing, compressive sensing and deep learning, will be combined
to extract full information from scan data and image priors to freeze the beating heart.
The specific aims H3 are: (1) Hyper Dataset: Projection datasets in the Radon space and the corresponding
ground-truth images without motion artifacts in the image space will be generated in simulation, experiments,
and clinical studies; (2) Hybrid Algorithm: A deep learning network and CS-module will be developed, integrated,
and accelerated within the ACID framework for limited-angle free-breathing cardiac CT reconstruction, which will
be shared on an open-source platform; and (3) Holistic Evaluation: The performance of our reconstruction
software will be characterized, the stability and generalizability will be investigated, and task-based clinical
applications will be demonstrated, including quantification of stenosis severity, aorta dimensions, and motion
artifacts within the clinical setting of individuals with atrial fibrillation, tachycardia, and irregular heart rates.
Completion of this project will yield a free-breathing cardiac CT algorithm with the unprecedented temporal
resolution of 60ms, a 230% improvement over the state-of-the-art, allowing cardiac CT without clinically-relevant
motion artifacts. This represents a major step towards the integration of model-driven and data-driven methods
for CT image reconstruction, with a lasting impact on not only CT but also other tomographic modalities.

Public health relevance
Narrative This project will develop an artificial intelligence (AI)-based approach to freeze the beating heart in CT images within a 60-millisecond time window (1/20 of a heart beat), eliminate the motion blurring of coronary arteries in these images, and facilitate analysis of plaque buildup in these arteries, which is the main cause of heart attacks. Our methods will not require patients to hold their breath during the CT exam, and eliminate the need to use beta-blocker drugs to slow patients’ heart rates. Our AI-empowered computational framework will offer major benefits to patients who have the high and irregular heart rates that commonly occur in older adults many of whom experience atrial fibrillation, and also greatly improve image quality of legacy CT scanners.